A Commercial Platform for High-Volume Behavior and Electrophysiology Research

PROJECT SUMMARY
Inter-subject variability in brain activity and behavior is currently difficult to study and/or
overcome during statistical analysis, especially for studies of complex cognitive functions.
Larger cohorts of animals are often needed per study, but the available tools used to record
spiking activity from large ensembles of neurons as animals are performing standardized
behaviors require intense human labor and attention, limiting their applicability for high-
throughput applications. A new type of research tool will be developed and commercialized that
is specialized for high-throughput detailed neural measurements in freely behaving rats. We will
develop an automated apparatus that can be used in the animals’ own home cage
environments. The system will administer user-defined operant behavioral protocols and
simultaneously record spiking activity from hundreds of electrodes using miniature datalogging
technology. The battery-powered loggers will charge wirelessly using cutting-edge technology
that can sustain high power transfer over the majority of the volume in the cage. All parts of the
system, including the neural recorders, will operate automatically and continuously, reducing
the amount of human labor required to run large-cohort studies.

Public health relevance
PROJECT NARRATIVE A neuroscience research tool will be developed that reduces human labor and associated costs of studies involving chronic in vivo electrophysiological recordings of ensemble spiking activity in rodents. The tool will enable labs to automate behavior-electrophysiology experiments inside standard rat home cages, which will in turn allow them to study larger cohorts of animals.